Complex Amines from Simple Amino Acids via Pyridoxal-Mimicking Radical (Photo)Catalysis

Project Summary
The overarching five-year goal of the proposed research thrust is to realize a wholly new avenue in biomimetic
organic synthesis, whereby rationally designed PLP-mimicking scaffolds can enable open-shell radical
pathways, particularly by using visible light, for challenging bond cleavages and formations. This will be enabling
in the synthesis of complex primary amines from unprotected amino acids, providing rapid access to molecular
complexity, leveraging the inherent sustainability and accessibility of bio-derived precursors. From a mechanistic
standpoint, PLP-mimicking synthesis has operated in a single manifold (α-deprotonation) for the past 50 years
– albeit with substantial practical advances – mimicking PLP-dependent transaminases. This proposal posits
that other PLP-dependent mechanisms can be realized “ex vivo”, provided substantial kinetic barriers, which are
overcome in enzyme active sites through exquisite stereoelectronic control, can be subverted through distinct
mechanistic pathways. First, a “synthetic photodecarboxylase” platform is described, wherein the natural, but
kinetically-difficult, 2e--decarboxylation pathway is diverted to a radical decarboxylation via charge-transfer
excitation of a PLP-like amino acid Schiff base, which triggers oxidation to a carboxyl radical, inducing rapid
decarboxylation. This provides ambient access to the key quinonoid intermediate common to PLP-dependent
mechanisms. From this intermediate, a bevy of functionalizations could be realized, allowing for decarboxylative
synthesis of complex 1º amine products. Catalyst SAR demonstrate the necessary components of a catalytic
system and control over post-decarboxylation reactions. Elaboration of this platform to asymmetric catalysis is
proposed, taking advantage of the wealth of chiral PLP-mimicking catalysts for e.g. Mannich reactions. Second,
drawing inspiration from PLP-dependent radical aminomutase enzymes, a platform for amination of C-centered
radicals using amino acid esters as a source of “NH3” is described. This platform relies on umpolung via highly
polarized imines to trap nucleophilic C-radicals at the electrophilic N-terminus of an imine, followed by β-scission
fragmentation of the amino acid ester to generate the newly aminated product, with simple esters (e.g. EtOAc)
as the sole byproduct. This will be applied intramolecularly for a hook-and-slide strategy for the translation of
abundant α-amino acids into synthetically challenging β-, γ-, δ-, and ε-amino acids. The platform will be realized
catalytically for intermolecular amination of C-radicals, with the potential for asymmetric amination via either
chirality transfer from abundant chiral amino acid precursors or via asymmetric catalysis. The proposed research
is highly innovative, as radical PLP-mimicking catalysis is wholly undescribed in the literature, with just one
example of engineered enzymatic catalysis merging radical mechanisms with PLP-dependent enzymes.
Furthermore, the studies described herein are significant as they will both open up new avenues of organic
synthesis, particularly within organocatalysis, and provide rapid access to complex primary amines of
pharmaceutical relevance from simple, abundant amino acids.

Public health relevance
Project Narrative Pyridoxal (Vitamin B6)-dependent enzymes are relied upon in biology for challenging bond-forming and bond- breaking events and are essential in amine synthesis and metabolism; nevertheless, the repertoire of ex vivo synthetically-useful biomimetic transformations inspired by pyridoxal is conceptually quite limited, despite the extreme importance of complex amines in pharmaceutical development. This proposal describes a dramatic expansion of the pyridoxal-mimicking synthetic toolbox, unveiling new mechanistic pathways inspired by two under-looked classes of pyridoxal-dependent enzymes. The formulated reactions, inspired by decarboxylases and radical aminomutases, would enable the decarboxylative functionalization of amino acids to complex primary amines via a novel photochemically-induced radical decarboxylation and the use of simple α-amino esters as substrates and reagents for amination of carbon-centered radicals, respectively, resulting in a broadly applicable platform for the transformation of abundant amino acids into complex, pharmaceutically-relevant primary amines.